RML Core

RML Core Project Summary
Maximizing creative partnerships to deliver community-driven health outreach, the RML Team
contributes to the development of a diverse workforce and reaches underrepresented
populations by fostering outreach, engagement, and training programs aligned with cultural
humility.
These programs enable NNLM members to bring biomedical, health, public health and cultural
and environmental health information resources and data within easy reach of researchers,
health professionals, the public health workforce, educators, and the public.
The RML Team:
• Activates large-scale outreach projects with proven partners to replicate programming
throughout Region 1 and nationally.
• Delivers TechQuity, a technology and digital equity technology improvement program
dedicated to health and digital equity.
• Develops a data-ready workforce in collaboration with The Carpentries.
• Increases student engagement and contributes to the development of a diverse
workforce by tailoring curriculums and outreach models for specific health careers.
• Launches an annual virtual symposium related to NNLM initiatives.
• Develops a new certificate program focused on social justice and health equity.
• Pilots a meaningful program on end-of-life care, partnering public libraries and
community-based organizations with hospitals for implementation.